Indiana CARES (Creating Accountability and Building Relationships to Eradicate Sex Harassment)

Project Summary
We address calls for research that will inform paradigm-shifting interventions to address sexual
harassment and racialized mistreatment of advanced trainees in biomedical research training
environments (NOT-OD-21-150). Our approach is grounded in power-approach and moral
licensing theories which examines how personal embodiment of power in the context of structural
inequities mobilizes harassing and racist mistreatment of trainees. We conduct rigorous
experience sampling research to capture the effects of research mentors’ daily power
embodiment on mentees’ experiences of sexual harassment and related mistreatments to better
understand these linkages and exacerbating factors. We further develop a comprehensive
intervention, Indiana CARES (Creating Accountability and Building Relationships to Eradicate
Sexual Harassment), designed to break the links between power and harassment and change
the training environment climate and practices so that mentees can thrive. For Aim 1, 320 pairs
of mentor-mentees in biomedical research training programs will be solicited to participate in a
10-day daily survey study. Mentors will complete daily measures of their power embodiment,
affective states, and moral licensing cognitions. Mentees will complete evening measures of their
experiences of mistreatment by their mentors. Qualitative data on the nature of any mistreatment
they experience will be solicited. We further examine whether racial minority mentees are
particularly vulnerable to experiencing racialized sexual harassment, microaggression and
ostracism and we explore how structural characteristics, such as the relational demography
(race/gender matching) of mentor-mentee dyads, as well as the program’s tolerance for
harassment and mistreatment, as reported by mentees, affects these linkages. For Aim 2,
biomedical, research-active faculty at IUPUI and IUSM will be randomly assigned to a treatment
or control cohort. Our intervention consists of a four-part training program focusing on addressing
the role of power and moral licensing through perspective-taking and empathy training, followed
by a program-centered organizational change initiative supported by Program Enhancement
Grants (PEGs). Research will examine the impact of the training on breaking the power-
harassment link for mentors and improving their sensitivity to harassment and racial mistreatment.
Furthermore, our research will examine the impact of the full Indiana CARES intervention on
improving the climate for sexual harassment intolerance and increasing mentees’ sense of
belongingness and early career outcomes through reductions in harassment and racist
mistreatment. We replicate this program for the control cohort in the final year.

Public health relevance
Project Narrative This research addresses the need to eradicate sexual harassment and racially motivated mistreatment of graduate students and post-doctoral fellows in biomedical research training programs so that women and racial/ethnic minoritized students can thrive and contribute to scientific discovery. We examine the role of mentors’ power on their proclivity to sexually and racially harass and exacerbated by power-based structural elements of the training environment, and we develop a comprehensive intervention to dismantle those forces.